Age-dependent role of type I interferon in Bordetella pertussis pathogenesis

PROJECT SUMMARY

Recent levels of the bacterial disease pertussis are at their highest in 60 years. However, the
currently used acellular pertussis vaccine is inadequate and no effective therapies exist for treatment of
pertussis. Since antibiotic therapy is ineffective, host-targeted therapeutics are needed. However, we still
have a very poor understanding of the pathogenesis of pertussis and therefore it is unclear which host
targets are appropriate for therapeutic intervention. By RNAseq transcriptomics analysis, we found that
the type I interferon (IFN) receptor subunit IFNAR1 was the most significant upstream activator of mouse
lung genes differentially expressed in response to Bordetella pertussis infection. Type I IFNs are key
cytokines in immune responses and antiviral defense, but they also exacerbate inflammation and
pathogenesis in a variety of disease models. Type I IFNs have diverse effects on a variety of bacterial
infections, being protective for some and deleterious for others. Our preliminary data indicate that
expression of type I IFNs is upregulated in the lungs of B. pertussis-infected adult mice and that they
exacerbate lung inflammatory pathology. However, in infant mice, in which the pathogenesis of pertussis
is markedly different from that in adult mice (as in humans), our preliminary data suggest that type I IFN
signaling is protective against B. pertussis disease, indicating age-dependence of type I IFN effects.
We have also been studying sphingosine-1-phosphate (S1P) receptor ligands as candidate host-
targeted therapeutics for pertussis. An S1P receptor ligand drug, FTY720, is used in humans as a
therapy for relapsing-remitting multiple sclerosis, and other similar drugs are in clinical trials for various
inflammatory disorders, demonstrating the translational potential of these drugs. In published studies, we
found that administration of a single dose of S1P receptor ligands to B. pertussis-infected adult mice
significantly reduced lung inflammatory pathology. Furthermore, our preliminary data suggest that S1P
receptor ligand treatment reduces inflammation by downregulating type I IFN signaling in infected adult
mice, consistent with the hypothesis that type I IFNs exacerbate lung inflammatory pathology.
Therefore, the aims of this proposal are to test the hypotheses that (i) type I IFNs contribute to
lung inflammatory pathology and pathogenesis of B. pertussis disease in adult mice but are protective in
infant mice, and (ii) S1P receptor drugs attenuate lung inflammatory pathology in B. pertussis-infected
adult mice by inhibiting type I IFN receptor signaling. We will use a combination of mouse infection and
cell culture studies to test these hypotheses and investigate mechanisms, and we will take advantage of
genetically altered mice that impact type I IFN receptor signaling. Identification of host targets and
development of novel therapeutics for individuals suffering from debilitating and sometimes fatal pertussis
will have a major public health impact on this disease.

Public health relevance
PROJECT NARRATIVE Pertussis is a serious disease that is re-emerging in epidemics despite widespread vaccination and it is the only vaccine-preventable bacterial infectious disease that is on the rise in this country. Currently there are no effective treatments for individuals suffering from this prolonged and debilitating disease. In this project we plan to study how Bordetella pertussis bacteria cause this disease and how we might develop a novel treatment for pertussis.